STUDIES OF PHARMACOLOGIC EFFECT OF L-ASPARAGINASE

The overall objective is to explore the pharmacologic effect of ASNase as measured by the degree and duration of ASN depletion in patients with acute lymphoblastic leukemia being treated with intramuscular ASNase. This protocol uses the core laboratory only, for analysis of samples.